Alcohol Vapor Self-Administration in Rats

Project Summary / Abstract
A major issue in the alcohol field is the lack of animal models of the voluntary induction and maintenance of
alcohol dependence. Rats will readily self-administer alcohol, but the amount of alcohol consumed is very low
and thus does not produce blood alcohol levels that are clinically relevant for alcoholism (100-200 mg% for
several hours per day). In the previous funding period, we successfully developed a novel model of the voluntary
induction and maintenance of alcohol dependence in rats using chronic intermittent ethanol vapor self-
administration (EVSA). In this model, animals exhibit severe addiction-like behaviors, including somatic signs of
withdrawal, anxiety-like behavior, hyperalgesia, and responding despite adverse consequences (on a
progressive-ratio schedule of reinforcement) after 6 weeks of EVSA. The current proposal seeks to further
develop this paradigm, identify the neuronal networks of the voluntary induction of alcohol dependence, and
characterize a novel model of voluntary “extreme binging.” Extreme alcohol binging is a critical societal issue
and one of the priorities of the NIAAA Strategic Plan 2017-2021. Binge and extreme binge drinking are
particularly troubling because they increase the risks for blackouts, alcohol poisoning, sexual assault, sexually
transmitted diseases, poor academic performance, and developing AUD. By combining alcohol vapor self-
administration with state-of-the-art brain mapping techniques, we will identify neuronal networks that drive
alcohol drinking and relapse after the voluntary induction of alcohol dependence. Our data show that both the
passive and active administration of alcohol vapor produces the escalation of alcohol drinking, increases the
motivation to obtain alcohol, and increases relapse, but the voluntary induction of dependence is characterized
by the specific recruitment of dorsomedial striatum (DMS) and dorsolateral striatum (DLS) neurons during
withdrawal. We also propose to further characterize alcohol drinking and relapse in animals that are previously
made dependent by EVSA vs. animals that are made dependent by passive exposure to alcohol vapor. Finally,
we propose to validate and fully characterize a novel model of extreme alcohol binging, in which animals self-
administer alcohol vapor to the point of reaching blood alcohol levels of ~400 mg%, losing consciousness
(“blacking out”), and exhibiting short-term memory loss. Results from these studies will provide a full
characterization of alcohol drinking and relapse in animals that voluntarily develop dependence and will unveil
neuronal circuits that underlie the voluntary induction and maintenance of alcohol dependence. Results from this
proposal will also provide a novel animal model to study and characterize extreme alcohol binging in rodents.
The proposed studies have the potential to have a sustained and powerful impact on the field of addiction
because they could unveil neuronal targets that are specifically recruited during the voluntary induction of alcohol
dependence and extreme binging that could be used to develop novel therapeutic approaches.

Public health relevance
Project Narrative We recently developed a novel model of the voluntary induction and maintenance of alcohol dependence in rodents using chronic intermittent ethanol vapor self-administration (EVSA). We propose to use brain mapping techniques to identify the neuronal networks that mediate the voluntary induction and maintenance of alcohol dependence and use the EVSA model to study extreme alcohol binging. Results from these studies will uncover neuronal targets that are specifically recruited during the voluntary induction and maintenance of alcohol dependence and will characterize a novel model of voluntary extreme alcohol binging, a key priority of the NIAAA Strategic Plan.